Translational Explorations in Substance Use Disorders

PROJECT SUMMARY/ABSTRACT
Drug overdose deaths and substance use disorders (SUDs) constitute a major, high-impact health problem in
the U.S. This renewal of the training grant Translational Explorations in Substance Use Disorders (T32
DA007287) at the University of Texas Medical Branch (UTMB) proposes to address the large gap between the
problem and efficacious solutions by mentoring the next generation of innovative scientists committed to the
search for answers. Under the auspices of the UTMB Center for Addiction Research (CAR), the history of our
Training Program demonstrates a wealth of career development successes, extensive collaborative networks,
and expertise in cross-disciplinary SUD research conducted with contemporary technologies. Currently, 56% of
our mentees are females, while 50% are URM mentees; 12% of our mentees self-disclosed as SGM or persons
with disabilities or disadvantaged backgrounds. Our T32 mentors include 50% women with 19% having URM
status. During the current funding period, 95% of our mentees were retained in research positions with ~74% in
SUD-related careers. Together, pre- and postdoctoral mentees generated a total of 140+ publications in the past
10 years (36 during the current funding period with numerous manuscripts in progress). Our predoctoral mentees
are producing, on average, six published manuscripts each (two as first-author). Of our postdoctoral mentees
from the current funding period, three have become faculty, two are in residency programs, one is in industry.
Moving forward, our goal is to provide mentees with key transferrable skills accessible through innovative SUD
mechanistic studies, drug discovery projects, prevention, and public health initiatives. We will harness Health
Analytics to accomplish this goal by incorporating research strategies across barriers towards biobehavioral
signatures of SUDs. Our objectives are to (1) integrate diverse mentees into SUD research; (2) instill mastery of
SUD sciences and key skills through outstanding role models; (3) impart critical thinking skills to tackle strategic
questions in our field; (4) provide first-rate preparation for independent careers in SUD sciences; (5) inculcate
best practices in scientific ethics, rigor, diversity, equity and inclusion (DEI) across the full spectrum of
possibilities; (6) broaden the dissemination of our learnings though peer-reviewed publications and community
venues to improve public health, productivity, and life fulfillment. Strategies to achieve these objectives include
providing well-funded, state-of-the-art research opportunities, facilities, effective mentoring plans (Mentor
Mosaics), challenging curricula, supportive interactive programs (e.g., SciPopUp, short-term research rotations),
plus first-rate activities that develop the professional skills needed for advancement towards an independent
career (e.g., Grant and Publication Action Group, Innovation and Entrepreneurship). The outcome of our efforts
is successful, diverse trainees as complete scientists equipped with the tools to advance the mechanistic
knowledge of SUDs as well as deliver new approaches to alleviate the challenges with drug misuse and SUDs.

Public health relevance
PROJECT NARRATIVE Drug overdose deaths, misuse and substance use disorders (SUDs) collectively constitute a major, high-impact health problem in the U.S. This competitive renewal of the training grant Translational Explorations in Substance Use Disorders (T32 DA007287) at the University of Texas Medical Branch addresses the large gap between the problem of SUDs and efficacious solutions by applying innovative mentoring and research approaches to fully equipping the next generation of SUD scientists to greatly enhance therapeutic strategies.